Decision dynamics during a continuous-time foraging task: a reinforcement learning approach

Project Summary
It is likely that evolution has strongly shaped the neural circuitry of the reward systems to optimize
performance in the many tasks involved in foraging for resources, a critical part of every animal's life. This
proposition was the inspiration for the development of “optimal” foraging theories, such as the marginal
value theorem (MVT), which derive analytically the foraging behavior (sequences of choices) that
maximizes the long-term rate of reward, usually considered to be energy intake. While these analytic
theories have had some success in describing animal behavior, the theories themselves rely on strict
assumptions about the environment that do not hold in many natural situations and are not flexible enough
to generalize to more complicated environments or other tasks. Therefore, the end goal of this project is to
understand which of a family of general-purpose decision (reinforcement-learning) algorithms is most likely
to be employed by the brain to solve value-based tasks and to use this knowledge to predict under what
circumstances these algorithms will lead to optimal or suboptimal behavior.
With this project, I will improve our understanding of animal decision processes in these more natural
environments by performing a foraging experiment that is continuous in time and violates many of the
assumptions that prior analytical theories of foraging rely on. Rats motivated by thirst will be allowed to
sample freely from two or three (palatable or aversive) tastant options (“patches”) in an open field and,
critically, will be allowed to direct their encounters with the options, something which past experiments have
lacked. Measurements of licking (consumption) behavior at each of the tastant options will allow me to
measure the decision dynamics of the rat over several 1-hour sessions. In particular, I will measure how the
sampling times at each option correlate with the values of the alternatives to gain insight into how rats
combine the values of available options to make decisions.
As a complement to this behavioral task, I will simulate a set of reinforcement learning agents that vary in
the rules used for learning action values, choosing actions, and planning actions. By quantitatively
comparing the decision behavior of these artificial agents to that obtained from rats I will determine which of
the simulated agents best reproduces the rat behavior, giving insight into the decision algorithms used by
rats and providing a direction for future electrophysiological recordings during this task. Importantly, this
comparison of animal behavior with that produced by artificial agents will allow me to assess how close to
“optimal” rat behavior is and, in the cases where it is suboptimal, to provide quantitative explanations for
why it is so.

Public health relevance
Project Narrative Much of the neural circuity of the brain's reward system is known, however it is unknown what type of reward-learning algorithms it implements and whether these algorithms differ significantly across individuals. Understanding which of the many reward-learning methods animals (and humans) use is critical since pathologies in this system underlie learning and motor disorders and will help explain how cycles of sub-optimal decisions, such as addiction, can develop. This project will infer which of these algorithms rats use to choose between only palatable, only aversive, or a mix of options in a naturalistic foraging task making testable neurophysiological and behavioral predictions in the process.